Mitigate the effect of HIV-related stigma through a resilience approach

ABSTRACT
Stigma and discrimination related to HIV and AIDS (“HIV-related stigma”) have been identified worldwide as
major barriers to HIV treatment and care, posing challenges to HIV prevention efforts and provision of adequate
care, support, and treatment. Despite decades of global efforts to tackle HIV-related stigma, previous
interventions designed to reduce stigma have been largely ineffective. The knowledge gaps and challenges for
combating HIV-related stigma are partly rooted in the complexity and diversity of the stigma and partly in the
limitations in current conceptualization of stigma reduction efforts. Recent research, including our own
preliminary data, has shown the promise of resilience approaches that focus on the development of strengths,
competencies, resources, and capacities of people living with HIV (PLWH) and those of their real or surrogate
family members and healthcare facilities to prevent, reduce, and mitigate the negative effects of stigma. However,
the resilience approach, while hypothesized, has not been widely tested in intervention trials. In the current
application, we propose to develop, implement, and evaluate a theory-guided, multilevel multimode resilience-
based intervention via a stepped wedge randomized trial among 800 PLWH and their real or surrogate family
members as well as 320 healthcare providers in Guangxi, China where we have built a strong research
infrastructure and community collaboration through NIH-funded research since 2004. The primary outcome will
be viral suppression among PLWH, and the intermediate outcomes will include resilience resources at the levels
of individuals, the real or surrogate family members, and healthcare facilities as well as chronic stress response
and adherence to treatment and care. The proposed study is innovative as it addresses a number of knowledge
gaps in HIV-related stigma reduction intervention research based on both a conceptualization of stigma reduction
and advancement in intervention research methodology (e.g., multilevel and multi-component intervention
modality, a stepped wedge design, addition of biomarkers to assess the effects of stigma, and targeting primary
HIV clinical outcomes such as viral suppression). The proposed research is significant as it addresses a critical
public health issue in the US and globally. The proposed intervention protocol, if proven efficacious, has the
potential to be replicated in other low- and middle-income countries to mitigate the negative impact of stigma on
the HIV treatment and care continuum.

Public health relevance
Project Narrative. Despite decades of global efforts to tackle HIV-related stigma, our understanding of the effects of stigma and discrimination on HIV clinical outcomes remains inadequate. While resilience-based approaches hold great promise for mitigating the negative effects of HIV-related stigma (and other social stigma) on clinical outcomes of people living with HIV (PLWH), such promise has only been hypothesized but not empirically tested. The proposed study will be one of the first large scale efforts to examine whether resilience among PLWH can be fostered and sustained through a multilevel and multi-component behavioral intervention and whether such a resilience-based intervention can substantially improve the quality of treatment and care among PLWH in low- and middle-income countries as well as in other nations across the globe, including the United States.